UI Advancing Research in Immunization Services Network Coordinating Center

Project Summary
Multiple forces are undermining US vaccination rates, resulting in the reemergence of previously eliminated
diseases. Despite decades of intervention development to improve vaccination outcomes, most interventions
generally have little to no impact. This is especially true in rural areas of the United States. One reason why
existing vaccination interventions may fail is the underlying assumption that non-vaccination is the result of
either not knowing, or having misconceptions, about essential aspects of vaccination. However, the scientific
evidence from evaluations of vaccination interventions generally goes against this assumption. Drawing on
decades of research from political psychology and “motivated social cognition”, along with preliminary data for
this proposal, we argue that people find vaccine confidence or hesitancy more attractive to the extent that they
experience motivational factors to manage threats, reduce uncertainty, have cooperation-based social goals,
and prefer objective information. For example, in one of our prior studies we found higher intentions to “catch
up” on HPV vaccination for unvaccinated young adults that had stronger emotional reactions to rare threats,
greater aversion to changing what they think, and higher interest in scientific or numeric information. We
propose to improve how we promote vaccines by creating “motivational fit”, communicating vaccination-related
information in such a way that vaccine confidence satisfies an audience’s motivational goals better than
vaccine hesitancy. The overall objectives of this application are to 1) identify motivational factors that can be
used to alleviate specific dimensions of vaccine hesitancy and improve vaccine uptake, especially among rural
Americans, 2) create and test vaccination promotion strategies that have motivational fit for use with a public-
facing website tailored to addressing specific dimensions of vaccine hesitancy, and 3) lead the development of
connections among the ARISe Network centers and our other partners to identify and create innovative
solutions to address challenges in immunization services research and practice. At the conclusion of this
funding cycle, we will have advanced our theoretical and practical knowledge about immunization service
utilization, created a publicly accessible website to address vaccination concerns, made significant
contributions to ARISe activities, and facilitated connections among ARISe Network centers and our partners
that help generate innovative solutions to addressing the challenges facing immunization services utilization.

Public health relevance
Project Narrative The University of Iowa Advancing Research on Immunization Services Network Center (UI-ARISe) will serve as an ARISe collaborating and coordinating center. We propose a new theoretical framework, “Vaccination as Motivation Social Cognition”, for understanding how people think, feel, and behave regarding vaccines and will develop and evaluate a new intervention target based on this framework, which we call “motivational fit”, to improve vaccine outcomes. Specifically, we will identify psychological drivers of specific dimensions of vaccine hesitancy for US adults living in metropolitan and non-metropolitan areas and develop vaccination promotion strategies that refocus the psychological driver for each vaccine hesitancy dimension to align with vaccine confidence and immunization service utilization.